Decoding the regulation and function of GZMK within tumor-infiltrating CD8+ T cells

Project Summary/Abstract
The emerging roles of granzyme K (GZMK)+ CD8+ T cells in conditions associated with defects in immune
regulation, from rheumatoid arthritis to inflammaging, have garnered significant interest. The infiltration of GZMK+
CD8+ T cells is a prominent feature of the tumor microenvironment (TME) across several human cancers, and
yet their role and regulation remain undefined. Recent studies indicate that tumor-infiltrating GZMK+ CD8+ T cells
display distinct spatial and functional characteristics compared to other CD8+ T cells within tumors. Notably, high
levels of GZMK+ CD8+ T cell infiltration are associated with poorer prognosis in certain cancers. Unlike other well-
studied members of the granzyme family such as granzyme B (GZMB), the mechanisms driving GZMK
expression in CD8+ T cells within the TME and the effects of CD8+ T cell-derived GZMK on antitumor immunity
remain unclear. CD8+ T cell differentiation in the TME is shaped by the strength of T cell receptor (TCR) signaling
upon interaction with tumor-specific antigen. Studies have shown that persistent and overly-strong TCR
interactions drive T cell dysfunction, while insufficient TCR activation leads to functional inertness. Surprisingly,
my preliminary data suggests that both these extremes of TCR signaling strength predispose CD8+ T cells to
express GZMK. Furthermore, our group has demonstrated that GZMK can act as a novel initiator of the
complement cascade, a known impediment to antitumor immunity through its ability to recruit suppressive
myeloid cells to the TME. Building on these findings, I propose to investigate the mechanisms underlying GZMK
expression in CD8+ T cells within the TME and its impact on antitumor immunity. I hypothesize that GZMK
expression is driven in a subset of tumor-infiltrating CD8+ T cells that experience distinct TCR signaling,
leading to the upregulation of context-specific transcription factors (TFs), and that eliminating GZMK
from the TME will enhance antitumor immunity. To address my central hypothesis, in Aim 1, I will examine
the impact of TCR signaling strength and cell-extrinsic signals on Gzmk expression in tumor-specific CD8+ T
cells. First, I will assess the endogenous polyclonal CD8+ T cell response to cancer using Nur77 TCR-signaling
reporter mice. Then, using OT-I CD8+ T cells and tumors with OVA-SIINFEKL variations, I will assess how
controlled variation of TCR signaling strength impacts Gzmk expression. In Aim 2, I will identify the cis-regulatory
elements and TFs that modulate Gzmk levels in tumor-infiltrating CD8+ T cells by perturbing key epigenetic and
transcriptional regulators in vivo. In Aim 3, I will use Gzmk-deficient mice and CD8+ T cell-specific Gzmk-deficient
mice to explore its impact on overall antitumor immunity. Together, these studies aim to provide critical insights
into the regulation and function of GZMK in tumor-infiltrating CD8+ T cells and explore the potential of GZMK as
a novel target for therapeutic intervention in cancer immunotherapy.

Public health relevance
Project Narrative Recent studies indicate that expression of the pro-inflammatory molecule Granzyme K may be associated with poorer patient outcomes in infection, autoimmunity and cancer. The processes that determine how and why a tumor-infiltrating CD8+ T cell expresses Granzyme K, as opposed to the more potent antitumor molecule Granzyme B, remain unclear. This project will provide insight into the regulation of Granzyme K within CD8+ T cells and define its impact on the broader antitumor response, with the potential to identify new strategies for enhancing T cell effector function in cancer therapy.